Biological Mechanisms Core - RC2

Resource Core 2 (RC2) Biological Mechanisms Core: Project Summary
The identification of the etiologies of frailty and age-related vulnerability remains a crucial challenge for
gerontological research. Key to this challenge are the development of a better understanding of the underlying
biological basis that contributes to frailty and the identification of key biological pathways for the development
of interventions that might help prevent or alleviate frailty and loss of independence. The goal of Johns Hopkins
Older Americans Independence Center (OAIC) Biological Mechanisms Core (RC-2) is to enable the next
generation of frailty-related etiological discovery and to promote the translation of these discoveries into
clinically relevant diagnostic, preventive, and treatment modalities. This will be achieved through the provision
of high-quality biological and bioengineering measurement expertise, incorporation of new technologies,
analytical and computational expertise for genetics and omics analyses, and infrastructure necessary to attain
this goal. In order to comprehensively encompass the biological expertise necessary to study frailty-related
etiology, we have engaged a leadership team and internal consultants with complementary and synergistic
biological and translational expertise needed to unravel the complex biological mechanisms that underpin
frailty. They also all bring mentorship skills for trainees, and infrastructure to RC-2 and national prominence to
frailty research. The specific aims of RC-2 are to: 1) provide state of the art scientific expertise, infrastructure,
and technology necessary to advance biological and etiological research related to frailty, 2) provide access to
biological samples from human subjects and from animal models necessary to test hypotheses related to
frailty, 3) facilitate the translation of biological findings into interventions or prevention-focused clinical studies,
4) provide training, mentorship, and guidance to promising junior investigators around biological mechanisms
that impact frailty, and 5) provide institutional and external visibility for RC-2 related science and activities. Our
aims will be accomplished through close communication between the core leaders and their laboratories, close
partnership with the other OAIC cores, and the engagement of expert consultants in the highly relevant areas
of mitochondrial measurement, metabolomics, epigenetics, mouse model development, nanotechnologies for
diagnostic and treatment development, and the development of multi-omic analyses related to frailty. By
providing these resources, RC-2 will foster high quality research that elucidates clinically relevant biological
pathways that underlie frailty and related interventions that hold promise to attenuate frailty, related conditions,
and the loss of independence.